HYPOMAGNESEMIA &RENAL MG WASTING RENAL TRANSPLANT RECIP ON TACROLIMU

The objective of this study is to assess the correlation between hypomagnesemia and renal magnesium wasting with Tacrolimus blood level and dose in renal transplant recipients. They will also analyze for correlation with electrolyte abnormalities, acid base and volume status which are factors that affect magnesium excretion.